CHANGES IN SUBSTRATE FLUX AND THERMOGENESIS WITH INTENSIVE INSULIN THERAPY

Investigate the effects of intensive insulin therapy on the disturbances of substrate and energy metabolism in poorly controlled insulin-dependent diabetes mellitus.